Testing scalable, IVR-supported cancer prevention interventions for SGM in the rural Alabama Black Belt

This proposed research is consistent with the Notice of Special Interest NOT-OD-22-032. In this administrative
supplement, we will build on the infrastructure of our ongoing R01 parent grant [ ] – the
focused on
increasing physical activity among the general population [1]. Per the specific areas of research listed in the
Notice of Special Interest, we will use “methodological and strategic innovations to improve the recruitment and
retention of sexual and gender minority (SGM) individuals in any research activity.”
NCT03903874 Deep
South Interactive Voice Response (IVR)-supported Active Lifestyle (DIAL) intervention - that is
This research is important
because studies have shown that rates of inactivity-related chronic conditions are even higher among SGM
populations compared to their heterosexual counterparts. Contributing to this disparity are SGM-specific
barriers to physical activity (e.g., fear of discriminatory interaction in locker rooms) in addition to barriers
experience by the general population (e.g., limited time, commitment). These barriers are further exacerbated
by pervasive stigma and discrimination experienced by SGM communities in the Deep South. The state of
Alabama continues to have discriminatory laws (e.g., HIV/AIDS criminalization, lack of LGBTQ topics in
schools, exclusions of LGBTQ parents in adoption and foster placement) which contribute to massive mental
and physical health burdens among SGM adults. Given the potential to address a range of critical health
outcomes by increasing physical activity, new dynamic approaches are urgently needed, and we therefore
propose building on the current parent award to: Phase 1 (6 months) - Conduct phone interviews with 20 SGM
adults living in the rural Black Belt counties of Alabama to determine what aspects of the current recruitment
and retention strategies, as well as intervention content, should be adapted. Phase 2 (6 months) -
Finalize the DIAL intervention in collaboration with our community partners, academic experts, and IVR
The insights from the interviews will be presented to our
stakeholders in a virtual workshop to receive feedback and further inform the adaptation of intervention
procedures and content. Following the workshop, ur IVR developer from the parent grant will work with his
programming team to mock-up the
developer and programming team for implementation.
o
beta version of adapted intervention content for review and feedback at a
subsequent workshop. Feedback will be used to finalize intervention content changes for implementation.
Upon completion of the 12-month administrative supplement, we will be positioned for an R34 application to
conduct final usability testing and a pilot trial of the newly adapted physical activity intervention to address
health disparities amongst rural SGM populations in Deep South.

Public health relevance
Sexual and gender minority adults living in the rural, Deep South experience pervasive stigma and discrimination which further exacerbate a range of health disparities that are driven by physical inactivity. New dynamic approaches are urgently needed, and we therefore propose building on our current study to identify if and how retention and recruitment strategies, as well as intervention content, of an Interactive Voice Response-supported study can be adapted to meet the unique and pressing needs of sexual and gender minority people.